ETHANOL AND SNS FUNCTION IN TRAUMATIC BRAIN INJURY

Brain injury resulting from blunt head trauma remains a major medical complication, the sequelae of which are among the most common of neurologic problems. Because of the central role of the sympathetic nervous system in mediating bodily function and stress, it is hypothesized that the magnitude of SNS activation, as assessed by circulating catecholamine levels, will be an indicator of the severity of traumatic brain injury and, thus, will be useful in predicting patient morbitity and mortality. Conversely, hyperstimulation of the adenergic component of the SNS may itself negatively impact on the severity of illness and on patient survival by a variety of mechanisms. While acute ethanol abuse plays a major role in contributing to the trauma, its affect on SNS activation in the setting of traumatic brain injury is unknown. Consequently, catecholamine levels on admission in both intoxicated and non-intoxicated patients will be quantitated with the severity and type of injury as assessed by neurologic examination, neuroradiologic techniques, and CSF markers of brain damage. The efficacy of treatement with adrenergic blockade in both patient populations will be determined in patients in whom catecholamines predict a poor outcome.